Metabolic Basis of Disease - Phase 2

Project Summary:
The overall goal of this Phase 2 COBRE is to facilitate the growth of young intellectual talent and strengthen and
enhance the scientific infrastructure that will promote biomedical research discoveries that will enhance our
understanding of the metabolic aspects of different diseases. Specifically, we have identified three research
project leaders (RPLs) with scientific interests in different, but complementary aspects of disease research. Each
Research Project focuses on the metabolic aspect of a disease (HFpEF/heart failure with preserved ejection
fractions, HCC/hepatocellular carcinoma, and undernutrition and iron metabolism). Despite the diversity in
tissues and diseases of interest, each project strongly fits into Pennington Biomedical’s general mission, to
discover the triggers of chronic diseases through innovative research that improves human health across the
lifespan. In all aspects of our Phase 2 center, we are committed to prioritizing the promotion of diverse
perspectives.
Within this Metabolic Basis of Disease (MBD) COBRE proposal, we established two scientific cores in Phase 1.
The Preclinical Research Core brings together strengths from our Comparative Biology Core, Animal Models
and Behavior Core, and Genetically Engineered Models Core. The Molecular Mechanisms core integrates
aspects of our Genomic Cores and Cell Biology Bioimaging Core and provides mentoring and technical support
for the RPLs and PBRC faculty. In Phase 2, this core will have a stronger emphasis on bioinformatics and new
leadership. We will also establish a new Pilot and Feasibility Program to identify new RPLs and promote
metabolic basis of disease research.

Public health relevance
Project Narrative: The overall goal of this Phase 2 Metabolic Basis of Disease center is to continue to facilitate the growth of young intellectual talent, foster collaborations, and enhance the scientific infrastructure to promote biomedical research discoveries that will enhance our understanding of the metabolic aspects of various disease states.